Fluorescence Microscopy

In meeting the goals and objectives of FMIC, the center continues to:

-Service and maintain state-of-the-art equipment for unlimited access by intramural scientists.
-Provide investigator training in the use and analysis of fluorescence and optical-based techniques.
-Develop and optimize experimental protocols in collaboration with intramural scientists.
-Maintain and develop state-of-the-art analysis tools and protocols in collaboration with investigators
-Monitor and incorporate emerging fluorescence and optical technologies that will support the mission of NIEHS into FMIC.

During this fiscal year, FMIC has collaborated and supported 46 Principle Investigators from 8 branches/laboratories within the NIEHS DIR.

Some publications from this FY resulting from work in the center is listed in the bibliography below:

Bibliography

Chen SH, Han S, Hu CF, Zhou R, Gao Y, Tu D, Gao H, Feng J, Wang Y, Lu RB, Hong JS. Activation of the MAC1-ERK1/2-NOX2 Pathway Is Required for LPS-Induced Sustaining Reactive Microgliosis, Chronic Neuroinflammation and Neurodegeneration. Antioxidants (Basel). 2022;11(6). Epub 2022/06/25. doi: 10.3390/antiox11061202. PubMed PMID: 35740099; PMCID: PMC9220294.

Dickson MJ, Oh Y, Gruzdev A, Li R, Balaguer N, Kelleher AM, Spencer TE, Wu SP, DeMayo FJ. Inserting Cre recombinase into the Prolactin 8a2 gene for decidua-specific recombination in mice. Genesis. 2022:e23473. Epub 2022/04/28. doi: 10.1002/dvg.23473. PubMed PMID: 35475540.

Fang Y, Fan W, Xu X, Janoshazi AK, Fargo DC, Li X. SIRT1 regulates cardiomyocyte alignment during maturation. J Cell Sci. 2022. Epub 2022/03/10. doi: 10.1242/jcs.259076. PubMed PMID: 35260907.

Horton JK, Janoshazi AK, Nadalutti CA, Zhao ML, Stefanick DF, Wilson SH. Monitoring DNA polymerase mitochondrial localization and dynamics. DNA Repair (Amst). 2022;116:103357. Epub 2022/06/20. doi: 10.1016/j.dnarep.2022.103357. PubMed PMID: 35717762.

Li H, Bradbury JA, Edin ML, Graves JP, Gruzdev A, Cheng J, Hoopes SL, Miller-Degraff L, Fessler MB, Garantziotis S, Schurman SH, Zeldin DC. sEH promotes macrophage phagocytosis and lung clearance of Streptococcus pneumoniae. J Clin Invest. 2021. Epub 2021/10/01. doi: 10.1172/jci129679. PubMed PMID: 34591792.

Li R, Wang X, Huang Z, Balaji J, Kim TH, Wang T, Zhou L, Deleon A, Cook ME, Marbrey MW, Wu SP, Jeong JW, Arora R, DeMayo FJ. The role of epithelial progesterone receptor isoforms in embryo implantation. iScience. 2021;24(12):103487. Epub 2021/12/23. doi: 10.1016/j.isci.2021.103487. PubMed PMID: 34934913; PMCID: PMC8661479.

Liu J, Yu L, Castro L, Yan Y, Clayton NP, Bushel P, Flagler ND, Scappini E, Dixon D. Short-term tetrabromobisphenol A exposure promotes fibrosis of human uterine fibroid cells in a 3D culture system through TGF-beta signaling. Faseb j. 2022;36(2):e22101. Epub 2022/01/16. doi: 10.1096/fj.202101262R. PubMed PMID: 35032343.

Oyarzabal EA, Hsu LM, Das M, Chao TH, Zhou J, Song S, Zhang W, Smith KG, Sciolino NR, Evsyukova IY, Yuan H, Lee SH, Cui G, Jensen P, Shih YI. Chemogenetic stimulation of tonic locus coeruleus activity strengthens the default mode network. Sci Adv. 2022;8(17):eabm9898. Epub 2022/04/30. doi: 10.1126/sciadv.abm9898. PubMed PMID: 35486721.

Rodriguez KF, Brown PR, Amato CM, Nicol B, Liu CF, Xu X, Yao HH. Somatic cell fate maintenance in mouse fetal testes via autocrine/paracrine action of AMH and activin B. Nat Commun. 2022;13(1):4130. Epub 2022/07/16. doi: 10.1038/s41467-022-31486-y. PubMed PMID: 35840551; PMCID: PMC9287316.

Yan Y, Shi M, Fannin R, Yu L, Liu J, Castro L, Dixon D. Prolonged Cadmium Exposure Alters Migration Dynamics and Increases Heterogeneity of Human Uterine Fibroid Cells-Insights from Time Lapse Analysis. Biomedicines. 2022;10(4). Epub 2022/04/24. doi: 10.3390/biomedicines10040917. PubMed PMID: 35453667; PMCID: PMC9031958.

Zhou J, Li J, Papaneri AB, Kobzar NP, Cui G. Dopamine Neuron Challenge Test for early detection of Parkinson's disease. NPJ Parkinsons Dis. 2021;7(1):116. Epub 2021/12/18. doi: 10.1038/s41531-021-00261-z. PubMed PMID: 34916526.